Administrative Equipment Supplement for a Robotic System

NOT-GM-22-017 03-01-2022
Acquisition of a robotic system is eligible for the current R01 in with NIGMS (2 R01 GM098629-
10A1). The grant is active and enters its second year of funding on 04/01/2022. The grant will be
active for two years beyond the date of the request. This is a one-time request for equipment.

Public health relevance
NARRATIVE Signaling pathways control cell differentiation and other responses through a common set of proteins, such as the evolutionarily conserved Rho GTPase, Cdc42. Here, we explore the regulation of Cdc42, specifically turnover, interaction with an adaptor, called Smg GDS, and regulation by mucin to identify pathway-specific effects on signaling. High-throughput approaches with a robotic system will greatly enhance mechanistic insights into pathway-specific determinants of Cdc42 function.